Multimodal Nanoparticles for Severe Inflammation and Sepsis

Summary
Sepsis is a life-threatening, multifaceted condition that develops due to an uncontrolled host immune response
to an infection. A 2017 study reported an estimated 48.9 million incident cases of sepsis worldwide with total
sepsis-related deaths representing nearly 20% of all global deaths. It has been hypothesized that the clinical
heterogeneity and different sepsis endotypes, treatment modalities targeted only towards a single molecular
pathway, and timing of therapeutic intervention are major contributors to the poor clinical results. Survivors
generally suffer from additional morbidities for years, including higher risk of readmission, cardiovascular
disease, and cognitive impairment, due to the development of trained immunity and a state of immune
suppression. Our long-term goal is to develop a simple and broad-acting nanoparticle (NP)-based
immunotherapy to address the complex and multifaceted immune dysregulation in sepsis. Towards
this goal, we developed immunomodulatory nanoparticles (iNPs) – a ‘drug-free’ class of poly(lactic
acid) (PLA)-based NPs to augment multiple aspects of innate immunity and promote sepsis survival.
The objectives of this MPI R01 proposal are built upon several foundational findings by our team. First,
intraperitoneal administration of iNPs significantly improved survival in two representative mouse models
of sepsis, namely, lipopolysaccharide (LPS)-induced endotoxemia (sterile inflammation) and cecal ligation and
puncture (CLP) (polymicrobial sepsis) when applied as an adjuvant to an antibiotic regimen. Second, iNPs
utilize a multimodal mechanism of action that leverages both physical (nanoformulation) and compositional
(lactic acid) features to reduce Toll-like receptor (TLR) agonist-macrophage interactions and proinflammatory
responses, increase innate immune cell survival, and inhibit inflammatory signaling pathways. Third, iNP
treatment retained the population of large peritoneal macrophages (LPMs) in vivo, a critical cell type
required for sepsis survival. Herein, we propose a rigorous R01 research project to: 1) evaluate the inherent
immunomodulatory properties of a focused set of iNPs to achieve maximal therapeutic efficacy in the CLP
sepsis model; 2) identify the cellular and molecular mechanisms underlying iNP effects; and 3) determine the
therapeutic window for safe and effective iNP treatment. In Aim 1, we will investigate how select
physicochemical properties of iNPs contribute to modulated inflammatory responses, and bacterial clearance,
while comprehensively investigating their in vitro and in vivo cellular and molecular mechanisms to treat sepsis.
In Aim 2, we will establish the therapeutic window for iNP administration. Timing and dosing effects related to
iNP efficacy and organ function will be determined and iNPs will be assessed using distinct, clinically relevant
scenarios reflective of suspected and early onset of sepsis. If successful, our work is anticipated to identify a
novel and readily translatable, NP-based immunotherapeutic solution to improve patient outcomes in sepsis.

Public health relevance
Project Narrative Sepsis remains an undrugged disease, largely because current treatment strategies have failed to move beyond the conventional single-agent, single-target approach. This proposal aims to develop and mechanistically study a new class of multimodal ‘drug-free’ nanoparticle immunotherapies that augment innate immunity to overcome the multifaceted immunological deficits that develop during sepsis. If successful, this approach has the potential to herald a simple and clinically translatable solution to improve patient outcomes and survival in sepsis.